Improving Accuracy and Outcomes of Cancer Screening and Diagnosis

DESCRIPTION (provided by applicant): I am applying for a second five-year K05 Established Investigator Award to allow me to continue my cancer research agenda and to provide time for mentoring junior colleagues. The renewal application documents the degree to which the initial Award enabled me to succeed in each of these areas, and the specific ways in which support for five additional years would be put to use. The K05 renewal will allow me: 1) to reduce my current clinical and administrative duties by 50% FTE so that I can develop and refine my research into the accuracy and outcomes of cancer screening and diagnosis; and 2) to engage junior investigators in clinical studies and train them to conduct independent research. The ultimate goal of my own research is to improve cancer screening, detection, and care. I propose working with trainees on clinically significant and innovative projects in three areas: 1. Studies examining variability among pathologists in the interpretation of breast tissue and the impact of digital imaging technology and double reading by pathologist on interpretive performance. 2. Qualitative studies of physicians' attitudes and experiences communicating errors in medical diagnoses. 3. Studies of radiologist characteristics associated with the accuracy of diagnostic mammography. In terms of mentoring, I will continue the commitment I have made in the initial five years of K05 funding to mentor a diverse group of junior investigators who are planning or engaged in cancer-related clinical studies. Based on my experience to date, the trainees will be located both inside and outside of the University of Washington. I enjoy research and mentoring and look forward to doing more in the next five years.

Public health relevance
PUBLIC HEALTH RELEVANCE: This award will support protected time for Dr. Elmore to expand her clinical research program and continue mentoring junior investigators in the areas of cancer detection, diagnosis, and outcomes. Specifically, junior investigators will be mentored on projects in general epidemiology, cancer screening and diagnosis, and the role of technology in cancer care. Project Narrative This award will support protected time for Dr. Elmore to expand her clinical research program and continue mentoring junior investigators in the areas of cancer detection, diagnosis, and outcomes. Specifically, junior investigators will be mentored on projects in general epidemiology, cancer screening and diagnosis, and the role of technology in cancer care. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS 10.a. Research Plan Overview My goals in the research design sections (10-13) of this application are to: 1) Provide evidence of the high quality of my clinical research programs; 2) Showcase sources of data that my trainees can use; 3) Describe clinically significant and innovative ideas for projects that would not include junior investigators and/or would not be done without K05 supported time; 4) Provide evidence of an adequate pool of trainees. The ultimate goal of my research is to improve cancer screening, detection and care. Like most clinical investigators, I am involved in multiple concurrent research projects. In this K05 application I describe in detail the B-PATH R01 grant, which is just one of my currently funded research projects. This B-PATH project has great potential for numerous offshoot projects for future fellows and junior faculty member's projects (R01- CA140560; J. Elmore, PI; NCI; 7/1/09 through 6/30/14). The description that follows relate to the initial aims and sub-aims of this B-PATH project where trainees could be involved and will allow the reader to assess the quality of my work. I provide less detailed information on two other possible research areas for future trainees. I describe possible qualitative projects on communication of medical errors and then I describe projects on diagnostic mammography using data from my FAVOR grant (R01 CA-107623). K05 funding will allow me adequate time to mentor trainees on the projects described below and take full advantage of these national databases. 10.b. Specific Aims for Research Area #1 (B-PATH, pathology variability studies) We propose a series of studies to evaluate the extent and impact of variability in the interpretation of breast pathology. By studying possible sources of variability in breast pathology assessment and approaches to mitigate this variation, our comprehensive study has the potential to improve health care for the more than 300,000 women undergoing breast biopsy in the U.S. each year. To accomplish our goals, we will develop four test sets of breast biopsy cases with comparable representation of pathologic findings in each set. The test sets will be weighted to include a high percentage of cases with ADH and DCIS, with a relatively small proportion of benign and invasive carcinoma cases. A committee of international breast pathology experts will define the "gold standard" for diagnosis. A diverse group of community and academic pathologists from multiple regions of the U.S. will provide an independent review of the test sets during two distinct phases, with a wash-out period of 6 months between phases. During the second phase of the study, the pathologists will not be told that they are reviewing the same test set that they previously saw, and the cases will be randomly reordered and renumbered. The BPATH R01 study has the following Specific Aims: 1. To assess the accuracy of pathologists in the interpretation of breast pathology specimens and quantify the extent and possible sources of intra- and inter-observer variability. I would like to involve junior faculty members to take the lead in the two sub-aims that will involve identifying the features associated with accuracy among pathologists including patient characteristics such as age, race, density of breast tissue and background proliferative fibrocystic changes, and pathologist characteristics, including type of clinical practice and years of experience. 2. To compare the accuracy of pathologists viewing digitized images of glass slides to their performance interpreting original glass slides. To accomplish this aim, randomly selected pathologists will provide diagnostic interpretations on a test set of the original glass slides in one phase and in the other phase they will interpret the test set via digitized images of the same slides. 3. To assess whether the addition of independent double reading by two pathologists on all or a subset of cases can improve the accuracy of breast pathology interpretation. We will study two approaches that differ in how the final diagnostic interpretation is made: the highest interpretation of 2 independent pathologists and the majority interpretation of 3 pathologists. We hypothesize that the addition of double reading will be associated with improved interpretive performance for a subset of cases defined by the same patient and pathologist characteristics as specified in Specific Aim 1. 4. To quantify the implications of variability among pathologists' interpretations of breast specimens on short-term patient care and associated resource utilization within the U.S. population. Using decision-analytic modeling that incorporates data from Aims 1 and 3, we will characterize the range of potential harm due to false-positive and false-negative interpretations of breast pathology. The clinical and resource utilization consequences of variability will be studied. We will also estimate the impact of double- reading strategies on improving diagnostic accuracy and associated resource utilization within the U.S. population. This is an important aspect of our future study considering the economic aspects of alternative reading approaches in this era of escalating health care costs. The most significant aspect of the proposed work is our targeting of the diagnosis of ADH and DCIS, where previous studies reveal a concerning degree of diagnostic errors. This large multi-center study of community pathologists addresses a topic that has increasing clinical importance. Our research team includes international experts in breast pathology, statistical measurement of test accuracy, and studies of observer variability in clinical medicine, as well as an advisory committee of clinical experts in breast disease. The proposed work is innovative in the following ways: 1) we will go beyond a simple study that quantifies the existence of errors by studying the patient and physician correlates of inaccurate diagnoses; 2) we are assessing new digital technology and methods of double reading that may be used as tools to rapidly improve delivery of health care; and 3) we are using a systematic method to make projections of the real world implications of Aims 1, 2, and 3.